Cancer: Aging in the Driver's Seat

ABSTRACT Support is requested for a Keystone Symposia conference entitled Cancer: Aging in the Driver's Seat, organized by Drs. Sheila A. Stewart, Judith Campisi, Manuel Serrano and Eiji Hara. The conference will be held in British Columbia, Canada from March 7-10, 2021. Aging is the largest risk factor for the development of cancer, yet the classic aging research community and cancer researchers seldom interact. Therefore, the goal of this conference is to bring together individuals who study the systemic and local impact of aging, including accelerated aging brought on by chemotherapy, with cancer researchers, to share their insight and develop a better understanding of how aging impacts tumor initiation, progression, recurrence and response to therapy. By bringing these experts together, the intent of this conference is to create a more complete picture of the potential therapeutic landscape. One unique feature of this conference is the breadth of experts who focus on both the systemic and local aging environment and cancer and who also recognize varied paracrine interactions with heterogeneous neoplastic cells. Presentations will focus on emerging studies to enable attendees’ access to senior investigators, as well as new investigators spanning the diversity of disciplines called “cancer biology” and “aging”. In addition to invited speakers, time will be allotted for short oral presentations proffered from submitted abstracts and two integrated poster sessions for trainees and more junior attendees to present their research.

Public health relevance
PROJECT NARRATIVE It is well known that one of the largest risk factors for the development of cancer is aging; however, the researchers and clinicians in these two fields rarely interact. Therefore, this conference was developed to bring this gap and bring together individuals who study the systemic and local impact of aging, including accelerated aging brought on by chemotherapy, with cancer researchers. Participants will share their insights and develop a better understanding of how aging impacts tumor initiation, progression, recurrence and response to therapy with the intent to create a more complete picture of the potential therapeutic landscape.